ASM MOSAIC Program

ASM MOSAIC ABSTRACT
The American Society for Microbiology’s Maximizing Opportunities for Scientific and Academic
Independent Careers (ASM MOSAIC) program is a five-year initiative that will support early-career
scientists from minoritized groups to transition successfully from postdoctoral positions to tenure-track
faculty positions at research-intensive institutions. Increasing the number of faculty members from groups
historically underrepresented in science, technology, engineering, and mathematics is essential to
advancing biomedical research in the United States. While the number of postdocs from minoritized
groups has modestly increased over the last couple of decades, the number of faculty at research -
intensive institutions has yet to show a similar increase. Increasing the number of scientists from
minoritized groups who pursue doctoral degrees is not enough to correct this imbalance, which requires
targeted interventions to help them succeed. ASM MOSAIC’s three phases will cover the skills needed to
(1) secure a faculty position at a research-intensive university, (2) excel in a faculty position, and (3)
become a scientific leader. All three phases will include courses and workshops for skill development and
mentoring. The program’s first specific aim focuses on the foundational skills required to gain faculty
positions. To address this aim, the program will pair each scholar with a network of mentors to help them
assess different career pathways, develop the skills needed to maximize their productivity as a
postdoctoral fellow, and transition to a faculty position. The mentors will consist of (i) an institutional
mentor, (ii) a scientific mentor, and (iii) a career development mentor. The second specific aim will help
the scholars embark on a successful tenure-track career and will cover setting goals, building
relationships with department leadership, establishing a research laboratory, and managing work-life
balance. The scholars will also take grant and manuscript writing courses and participate in mentorship
training. The third specific aim focuses on catalyzing the scholars’ progression to scientific leadership.
This phase of the program will provide the scholars with the skills to acquire sustained research funding,
build a scientific reputation and professional network, and understand the business of science. To grow
their networks, the scholars will attend two conferences: the ASM-managed Annual Biomedical Research
Conference for Minoritized Scientists (ABRCMS) and ASM’s annual flagship meeting, ASM Microbe.
Microbiologists and immunologists research basic life processes, promoting knowledge that improves
public health and the economic and environmental well-being of the United States. The ASM MOSAIC
program will support early-career scientists from minoritized groups to achieve successful careers as
microbiologists and immunologists and prepare them to mentor the next generation of scientists.

Public health relevance
ASM MOSAIC PROJECT NARRATIVE The ASM MOSAIC program is relevant to public health by increasing the diversity of the microbiology and immunology fields, which is important for fostering innovation in basic science research and inspiring individuals from minoritized groups to choose careers in STEM. By helping scientists from minoritized groups realize successful careers at research - intensive universities, the ASM MOSAIC program will contribute toward NIH’s goal of enhancing diversity within the academic biomedical research workforce.